Multi-center observational study of the association between ventilation and cardiac arrest outcome

Project Summary/Abstract
Introduction: Out-of-hospital cardiac arrest (OHCA) is a major public health problem that affects over 350,000
adults in the US each year. Survival from OHCA remains unacceptably low despite promising advances over
the last decade. During cardiac arrest, all circulation stops. Cardiopulmonary resuscitation (CPR) combines
chest compressions (circulation) with lung inflation (ventilation) to restore perfusion and oxygenation to the
body. During the past decade, research focused on measuring chest compressions during CPR has led to
improvements in performance of chest compressions and improved clinical outcomes. However, ventilation
has long been a “neglected parameter” in CPR research, in part, because measuring ventilation during
OHCA and CPR is difficult. To address this problem, we developed a novel method for measuring ventilation
during CPR using thoracic bioimpedance (electrical resistance), which can be monitored through defibrillator
pads placed during CPR. Our studies showed that lung inflation does not occur in most ventilation attempts
with use of a bag-mask (BM) device during standard 30:2 CPR. We now have developed and validated a
machine-learning automated program that can measure ventilation during continuous chest compression
(CCC) CPR.
Objectives: The objectives of this study are to facilitate trial design development through measurement and
analysis of ventilation metrics using data from a large, comprehensive OHCA trial.
Methods: The study will use data from one of the largest, comprehensive OHCA multi-center clinical trial in the
world. The ROC CCC Trial database includes CPR resuscitation metrics, patient outcomes, and access to
defibrillator bioimpedance recordings. A validated method to identify bioimpedance ventilation waveforms has
been programmed into an automated computer algorithm, which will extract ventilation data from defibrillator-
monitor bioimpedance recordings from approximately 7,600 patients from seven ROC sites that participated in
the CCC Trial. Ventilation data will be matched with clinical data.
Specific Aims: 1) To determine ventilation frequency, incidence, bioimpedance waveform amplitude, and
inspiratory and expiratory times from the CCC CPR defibrillator and clinical files and 2) determine association
of variable with types of airway devices 3) To determine the association of BVM ventilation frequency,
incidence, and fraction with survival outcomes in the CCC CPR group and association with airway devices and
compare it with the 30:2 CPR group.
Significance: The results may provide evidence for a paradigm shift of our view regarding the importance of
ventilation during CPR and impact CPR training and guidelines. It will provide support for developing trial
design to test ways to improve ventilation during CCC and 30:2 CPR.

Public health relevance
This research will use a novel approach to measure ventilation from defibrillator-monitor files recorded during CPR in approximately seven thousand patients in a multi-center clinical trial. A prior study of the Resuscitation Outcomes Consortium Trial of Continuous or Interrupted Chest Compressions during CPR (CCC) showed that ventilation during standard 30:2 CPR is associated with improved patient outcomes. The proposed multi-center study will provide generalizable evidence to establish the importance of ventilation during Continuous Chest Compression CPR that could lead to a paradigm shift in CPR training, guidelines, and the delivery of resuscitation care to hundreds of thousands of people annually in the United States.